Role of proteolytic extracellular vesicles in halogen gas dependent chronic lung injury

Exposures to chlorine (Cl2) or bromine gas (Br2) may occur during industrial accidents and in the military arena.
Acute lung injury (ALI), followed by chronic lung injury (CLI) characterized by airway reactivity, fibrosis and
remodeling are significant concerns following halogen gas exposure; however, the mechanisms underlying this
transition to CLI after exposure to Cl2 or Br2 remain to be determined. An important tenet in CLI mechanisms is
protease dependent degradation and remodeling of the lung with neutrophil elastase (NE) considered a key
mediator. However, α1-anti-trypsin (α-1AT), an endogenous inhibitor of NE is typically present at higher levels
than NE raising the question how can NE mediate CLI in vivo. We recently discovered a novel mechanism where
NE is also bound to the surface of small exosome-sized extracellular vesicles (EVs) released by PMNs during
their activation and degranulation. Importantly, when associated with EV’s, NE is resistant to inhibition by α-1AT
explaining how NE can induce pathogenic effects in the face of abundant α-1AT. We showed that NE+EVs are
proteolytically active in vitro and in vivo; administration of NE+EV’s to naïve mouse airways led to reactive airway
disease and a progressive destruction of the airways in an NE activity dependent manner. Thus, NE+EVs are
novel mediators of CLI; a role for these proteolytic EVs in halogen gas toxicity has not been investigated. We
hypothesize that PMN-derived NE+EVs mediate chronic lung injury after halogen gas exposure. Preliminary
data supporting this hypothesis include demonstrating that NE+EVs are elevated in the airways post Cl2 gas
exposure, and importantly cause progressive lung injury when administered to naïve mice. We propose two
aims: Specific Aim 1: Determine the role of PMN-derived EVs in mediating CLI after halogen gas exposure.
Proposed studies will determine the temporal formation of EVs and changes in NE activity following exposure of
male and female mice, or rats, to either Cl2 or Br2 gas and relate these to the development of CLI assessed by
reactive airways, fibrosis and airway remodeling (morphometry). In addition, we will isolate EVs from lungs after
Cl2 or Br2 gas exposure, and then transfer them to naïve mice to evaluate their potential to cause CLI. Finally,
PMN depletion experiments will be conducted to confirm that formation of pathogenic EVs after halogen gas
exposure are derived from PMNs. Specific Aim 2: Determine the role of NE activity associated with EVs in
mediating CLI after halogen gas exposure. We will determine the role of NE by comparing Cl2 or Br2 toxicity in
WT or littermate NE-/- mice and the lung injury causing potential of EVs from these mice will be compared. Finally,
to validate and identify EV associated NE activity as a novel target for countermeasure development, we will
develop and test a strategy that specifically inhibits NE activity on EVs and then determine the ability of the latter
to cause CLI after transfer to naïve mice. Collectively, the proposed studies will delineate a new and common
mechanism for Cl2 and Br2 toxicity mediated by PMN-derived EVs and identify EV-associated NE activity as novel
target for future countermeasure development.

Public health relevance
The proposed studies will demonstrate a role for neutrophil derived EVs expressing proteolytic activity, that is resistant to endogenous protective mechanisms, in mediating toxicity after halogen gas exposure. Demonstrating this pathway may lead to the future development of a common therapeutic countermeasure targeting proteases specifically associated with EVs.